Rutgers Center for Environmental Exposure and Disease (CEED) - Administrative Core

ABSTRACT: ADMINISTRATIVE CORE
The Administrative Core (AC) serves as the central nervous system of the Center, continuously obtaining
feedback from all components, and integrating and synthesizing data into actions that ensure CEED fulfills its
mission of improving environmental health. The Core coordinates and supports research, training, community
engagement, infrastructure, and mentoring, and provides operational and fiduciary oversight. The AC obtains
and distributes resources from University matching funds and the grant to spur cutting-edge research and
training in environmental health. To accomplish this mission, CEED engenders a collaborative and supportive
transdisciplinary research environment that promotes interactions among researchers from a wide variety of
disciplines. The Core advances CEED goals through strategic hires, community engagement, and training and
teaching opportunities in environmental health science. The Core is also the nexus for mentoring and career
development activities for new or established faculty interested in environmental health Research. Core
members promote innovation, creativity, and recruitment of researchers to the field of environmental health
research through Pilot Grants and Career Development Awards. The Core coordinates solicitation and review
of these awards, and tracks all grant funding and publications of Center Members. The Core continually
evaluates CEED membership, Research Cores structure and tracks Facility Cores by maintaining the Center’s
LIMS system that tracks facility core use in real-time. This allows flexible and rapid reallocation of resources as
needed to optimize progress towards improving environmental health. The AC is also responsible for
communications with communities and stakeholders, and is responsible for maintenance of the Center’s web
page and social media activities. The Core holds Center and IAB meeting to review progress, get input from
Facility Core Directors and User groups, resolves conflicts, and set priorities. The AC also convenes an
External Advisory Boards and a Stakeholder Advisory Board to evaluate and facilitate CEED’s mission and
progress.